Predicting complications of diabetes with longitudinal metabolic trajectories

ABSTRACT
The prevalence of diabetes is increasing worldwide, with an estimated 463 million cases in 2019 (31 million
cases in the United States). Patients with diabetes suffer from a number of common and morbid complications,
including peripheral neuropathy (PN) and chronic kidney disease (CKD). In addition to diabetes, the metabolic
syndrome (MetS) has been firmly established as a risk factor for these complications. Unfortunately,
interventions that improve metabolic risk factors for patients with long-term metabolic impairment do not
completely prevent or reverse diabetic complications, which may be the result of the current timing of
interventions after metabolic risk factors have been present for many years. Importantly, very few studies have
assessed the longitudinal association between the MetS and diabetic complications; therefore, the ideal timing
of these interventions is unknown. Metabolic profiles worsen as age increases and there is a substantial
amount of heterogeneity between patient metabolic trajectories. What remains unknown is how changes in
specific aspects of longitudinal metabolic profiles (such as rate of change, cumulative effects, and changes
during specific risk-periods) affect the progression of these complications. It is also unknown whether the onset
of diabetic complications can be accurately predicted using longitudinal metabolic trajectories. Machine
learning algorithms are flexible and powerful analytic tools for making predictions with complex data; therefore,
they offer an ideal approach to predict diabetic complications using complex characteristics from metabolic
trajectories. Our initial aims are to (1) determine the association between metabolic trajectories, PN, and CKD,
and (2) develop a machine learning algorithm to predict these complications with detailed characteristics of
metabolic trajectories. We will accomplish these initial aims using three complementary and powerful
databases with differential metabolic complexity and sample size. First, we will determine if metabolic
trajectories are associated with and are predictive of diabetic complications using two cohorts of Pima
American Indians that have undergone detailed longitudinal metabolic and diabetic complication phenotyping.
Then, to determine if our results can be implemented in a large-scale, integrated United States health system,
our final aim is to (3) develop a comprehensive machine learning algorithm to predict complications for patients
with diabetes using the Veterans Affairs Corporate Data Warehouse database, which contains detailed
longitudinal medical information on over 3.1 million Veterans with diabetes from 1999-2021. Results from this
study will provide a novel understanding of the associations between metabolic trajectories and diabetic
complications. Ultimately, this data will inform future disease modifying interventions that reverse the metabolic
trajectories that are most predictive of diabetic complications.

Public health relevance
PROJECT NARRATIVE Diabetes and metabolic impairment are increasing worldwide and are associated with multiple complications, including nerve and kidney damage. The resulting symptoms severely impact quality of life in affected individuals. In this proposal, we aim to determine how long-term metabolic changes are associated with these complications, and if complications can be accurately predicted based on longitudinal metabolic measurements.